Southwest Transformative Educational Advancement and Mentoring (STEAM) Network

PROJECT SUMMARY
The Southwest Transformative Educational Advancement and Mentoring (STEAM) network leverages
partnerships at the University of New Mexico (UNM), New Mexico State University (NMSU), Northern Arizona
University (NAU), and Burrell College of Osteopathic Medicine (BCOM) to strengthen the career pipeline for pre-
and post-doctoral trainees and Early Stage Investigators (ESIs) engaged in cancer and cancer health disparities
(CHD) research. As Hispanic and Minority Serving Institutions, each of these institutions is poised to make much-
needed improvements in diversifying the CHD workforce in the Southwest region in the coming years. The
STEAM network affords many reciprocal benefits to the partners based on unique resources and training
opportunities at each of the partner institutions. Training Champions (TCs) representative of the minoritized
communities in the Southwest and who have training and expertise in cancer research will serve as role models
and near-peer mentors at each institution. TCs will have central roles in helping trainees to identify paths to
achieve their training and career goals. TCs will contribute to cancer research and skill building for
underrepresented minority pre- and post-doctoral students, as well as provide vital navigation support to ESIs
pursuing careers in cancer and CHD research. TCs will: 1) provide scholars with access to a comprehensive
array of resources and technical and professional career skill building tools to promote professional development
and attainment of educational and career goals; 2) facilitate scientific community engagement by linking trainees
in a diverse, multi-site and interdisciplinary network; 3) offer culturally responsive cancer and cancer health
disparities focused curricula; 4) aid in identifying mentoring opportunities; 5) assure inter-programmatic
connectivity. Southwestern populations across New Mexico and Arizona experience high rates of poverty, health
disparities, insufficient attainment of higher education, and geographic diversity that limits access to scientific
education and professional development opportunities. Formal connections of STEAM founding institutions will
ensure that trainees have greater access to the research education and training expertise of each institution to
meet the following objectives: 1) disseminate National Cancer Institute and Center to Reduce Cancer Health
Disparities priorities, and professional development offerings across an established and growing network; 2)
facilitate continued development of talent from the region's unique populations and those underrepresented in
cancer research through the provision of targeted cancer curricula and research skills training; 3) ensure
persistence and successful transitions beyond pre-/post-doctoral training through targeted mentoring and
programmatic offerings for early stage investigators that prepare them to assume productive cancer research or
health careers.

Public health relevance
NARRATIVE The Southwest Transformative Educational Advancement and Mentoring network brings together four Minority Serving Institutions across the US Southwest: University of New Mexico, New Mexico State University, Northern Arizona University, and Burrell College of Osteopathic Medicine to train the next generation of scientists in cancer and cancer health disparities. This network aims to foster the development of underrepresented and diverse scientists and investigators and strengthen the career pipeline for pre- and post-doctoral trainees and Early Stage Investigators. This proposed network will enhance the capacity of the scientific workforce to address cancer and cancer health disparities experienced by diverse populations in the Southwest United States.